Inter-modal Coupling Image Analytics

PROJECT SUMMARY
Almost all brain imaging studies now collect multiple imaging modalities, in an effort to derive measures of both
structure and function from diverse imaging sequences. While quantitative data scientists have focused on
machine learning approaches for predicting outcomes using multi-modal imaging, rigorous statistical methods
for examining the relationship between imaging modalities have lagged behind. At present, the lack of statistical
methodologies for assessing inter-modal coupling (IMCo) has left investigators with ad hoc solutions that lack
statistical power and are prone to type I error, posing a threat to scientific rigor and reproducibility. In this
application, we propose robust methods that leverage subject-specific measurements and use nonlinear
modeling to address complex relationships in brain maps or networks, while accounting for important covariates
(Aim 1). Furthermore, we will develop powerful approaches for assessing whether effects of interest (e.g.,
psychopathology, development) are enriched within brain networks (Aim 2). Assessment of this coupling
between statistical associations and brain networks will capitalize upon tools from statistical genomics (e.g.,
gene set enrichment analysis) to provide principled methods for conducting enrichment analyses using high-
dimensional, personalized brain networks. Finally, we will use these tools to delineate how trans-diagnostic
executive dysfunction in youth with mental illness is related to abnormalities in structure-function coupling within
brain networks (Aim 3). To do this, we will leverage three massive data resources: the Philadelphia
Neurodevelopmental Cohort (PNC; n=1,601), the Healthy Brain Network (n=3,200), and the Human
Connectome-Development (HCP-D; n=1,300) study Taken together, the proposed work builds upon the notable
success in the first project period, promising to yield rigorous and generalizable methods for delineating the
relationships between complementary measures of brain structure and function.

Public health relevance
PROJECT NARRATIVE The overarching goal of this proposal is to develop new tools for integrative analysis of relationships among brain imaging measures. Despite the rise of multi-modal imaging studies and the proliferation of derived measures available from each modality, very little work has explored relationships between modalities. The methods developed as part of this proposal will fill this critical gap in the field, and yield biomarkers of both healthy brain development and abnormalities related to executive dysfunction in youth.